Mobile Intervention to Enhance Physical Activity in the Chronically Ill

PROJECT SUMMARY This project aims to fill the urgent need for a safe and engaging intervention that promotes physical activity in a population of patients with chronic diseases (e.g., diabetes, asthma, osteoarthritis, and chronic heart failure). Compelling evidence suggests that physical activity is an effective therapeutic intervention for numerous chronic diseases. However, in spite of the wide consensus that physical activity should be an integral treatment component for many chronic diseases, most patients remain inactive1 due to a variety of barriers and obstacles they regularly encounter. We therefore propose to innovatively adapt an efficacious exercise-promoting intervention that targets sedentary employees2 to a population with specific needs and constraints that result from chronic disease and deliver this intervention as a mobile application that can be accessed via smartphone, tablet, or computer. We propose a program design that follows recommendations derived from a recent NIH-funded meta- analytic review of interventions to promote physical activity in patients with chronic diseases, which emphasizes the importance of behavioral activation as opposed to cognitive-behavioral intervention features.3 Our comprehensive mobile application is therefore composed of (a) an initial screening; (b) baseline physical activity (PA) levels recorded via wireless accelerometer device; (c) an assessment that elicits information regarding preferences for and barriers to PA; (d) goal setting; (e) daily e-mail or text messages stating the goal for the day, the type of exercise, and a link to a video demonstrating the exercise; (f) a brief check-in to determine whether the user is currently encountering a barrier (pain, fatigue, etc.) and tailored remediation for the barrier through social media functionality and expert advice; (g) prompts to execute the daily exercise; (h) integration of a wireless accelerometer device (e.g., Fitbit(R)) to supplement self-reported exercise data and to drive tailored feedback and goal setting; (i) check-in regarding activity completion (e.g., have you completed the exercise?, did you enjoy this exercise?, do you feel better after this exercise?); (j) immediate, personalized feedback on how executed physical activities contribute to goal progress; and (k) feedback reports for the primary care physician. Together these design features will promote and support a sustainable habit of regular PA in this vulnerable population. In a 30-day pre-post study, we will test preliminary efficacy and feasibility of this prototype intervention in a population of 38 adult patients with chronic osteoarthritis. The Phase I prototype program will be limited to demonstrating feasibility with individuals with osteoarthritis to control the overall scope of the Phase I project. We hypothesize that this intervention will engage this population and increase subjects' PA level from pre- to post-assessment. If this pilot efficacy trial yields satisfactory results, the Phase 2 project will expand the scope of the program to include all patients with additional chronic diseases (e.g., osteoarthritis, hypertension, diabetes, pulmonary disease).

Public health relevance
PROJECT NARRATIVE The prevalence of chronic diseases such as osteoarthritis, diabetes, asthma, and chronic heart failure poses a significant and costly public health issue to the United States. This project builds upon and updates an already proven to be efficacious, web-based exercise promoting intervention that targets sedentary employees. We propose to develop a web-based physical activity program that will fill the need for an exercise program for the underserved population of patients with one or more chronic conditions by providing them with a safe and engaging intervention that addresses their specific exercise needs and constraints as well as providing remediation of disease related barriers and obstacles. This web-based mobile application has the potential to increase physical activity, and consequently improve health outcomes, in the target group of chronically ill patients. __SpecificAimsTextDelimiter__ Specific Aims Over 133 million Americans have at least one chronic disease.6 To address this serious public health issue, the American Medical Association (AMA) and the American College of Sports Medicine (ACSM) recently instigated the "Exercise Is Medicine" initiative to encourage physicians to promote healthy physical activity levels for each patient at each visit and to make physical activity a standard of the global disease prevention and treatment medical paradigm.7 This effort is a result of compelling evidence accumulated over the past ten years documenting physical activity as an effective, evidence-based therapeutic intervention for numerous chronic diseases (e.g., osteoarthritis, diabetes, asthma, chronic heart failure, pulmonary conditions).8, 9 Unfortunately, although many physicians routinely encourage physical activity, they often lack the time and expertise to prescribe specific exercise plans or monitor compliance. Free or commercially available web- based exercise programs lack clinical trial data supporting their efficacy, and none of the currently available apps supports explicity physical activity in sedentary, chronically ill people. Furthermore, existing apps target only one specific disease group, thereby neglecting the vast majority of individuals who suffer from multiple chronic diseases. Therefore, in spite of the broad consensus that physical activity should be an integral treatment component of many chronic conditions, most chronic disease patients are inactive.1 The proposed physical activity (PA) promotion program for patients with chronic diseases will fill the need for an exercise program for the underserved population of patients with one or more chronic conditions. Disseminated directly through health plans, large disease management companies, and wellness providers and implemented through a mobile app, the program will provide patients with a safe and engaging intervention that addresses their specific needs and obstacles to exercise. The fully developed Phase 2 program will draw from an effacacious ORCAS program for sedentary employees2 and new comprehensive findings from an NIH-funded meta-analysis on the effectiveness of web- delivered exercise programs for patients with chronic disease.3 It will include the following components: (a) an initial screening to determine that the patient has chronic osteoarthritis; (b) a baseline physical activity (PA) level assessment via wireless accelerometer device; (c) an assessment that elicits information regarding preferences for and barriers to PA; (d) goal setting; (e) daily e-mail or text messages; (f) a brief check regarding possible barriers (e.g., pain, fatigue) with tailored remediation; (g) prompts to execute the daily exercise; (h) integration of a wireless accelerometer device (e.g., Fitbit(R)) to supplement self-reported exercise and drive tailored feedback and goal setting; (i) check-in regarding activity completion (e.g., "have you completed the exercise?," "did you enjoy this exercise?," "do you feel better after this exercise?"); (j) immediate, personalized feedback on how executed physical activities contribute to goal progress; and (k) feedback reports for the primary care physician. To control the scope of the Phase I project, the prototype program will focus on individuals with osteoarthritis. The Phase 2 project will expand the scope of the program to include patients with one or more chronic diseases (e.g., hypertension, pulmonary disease). Specific Aim 1: To develop an engaging mobile application accessible through smartphones, tablets, and desktop computers to promote PA among patients with chronic disease. Task 1. Convene Advisory Board regarding key intervention components and prototype application. Task 2. Complete three focus groups to solicit input on intervention components and prototype application. Revise accordingly. Task 3. Convene Advisory Board to review and integrate focus group input. Revise accordingly. Task 4. Create the integrated program. Task 5. Convene Advisory Board to review the prototype application. Revise accordingly. Task 6. Pilot test program usability with 10 subjects with chronic disease. Revise accordingly. Specific Aim 2: To evaluate program effects on PA levels in patients with chronic osteoarthritis. Task 7. Conduct an evaluation with 38 patients with chronic osteoarthritis using a within-subject, pre- post design with a 30-day intervention interval. Task Month 1 Month 2 Month 3 Month 4 Month 5 Month 6 Month 7 Month 8 Month 9 1 Advisory Board input 2 FG 1,2 FG 3 3 Advisory Board review/ revisions 4 Create application 5 Advisory Board review/revisions 6 Pilot/usability tests 7 Evaluation Figure 1. Project Timeline